Precision Alemtuzumab Therapy in Allogeneic HCT

Project Summary/Abstract
Many pediatric and young adult patients require an allogeneic hematopoietic cell transplant (HCT) for
treatment of deadly diseases besides cancer. Non-malignant disorders which are often treated with
allogeneic HCT include severe inborn errors of immunity, inborn errors of metabolism, marrow failure
disorders, and hematologic conditions such as thalassemia and sickle cell disease.
Reduced intensity conditioning (RIC) and reduced toxicity conditioning (RTC) regimens are commonly
used for patients with non-malignant disorders. RIC and RTC regimens usually contain alemtuzumab, a
humanized monoclonal antibody that is directed against CD52. CD52 is expressed by the majority of
lymphocytes and some other white blood cells. Alemtuzumab is included in RIC and RTC regimens for 2
main reasons. Alemtuzumab prevents graft rejection by depleting the recipient of lymphocytes
including T cells which may recognize the allogeneic graft as foreign. Alemtuzumab also reduces graft
versus host disease because alemtuzumab may linger at lytic levels through the administration of the
hematopoietic stem cell graft and result in lymphocyte depletion of the graft. Adequate prevention of
graft failure and graft versus host disease is essential to ensure successful outcomes and patient
survival.
We do not know the best way to dose alemtuzumab. We have previously reported that optimal peri-
transplant alemtuzumab concentrations of 0.2-0.6mcg/mL on the day of graft administration (Day 0)
reduce the risks of graft failure and graft versus host disease. Levels within this range also optimize
early immune recovery. It is important to be able to dose alemtuzumab so that the majority of patients
achieve Day 0 concentrations within this ideal target concentration window.
We have performed detailed alemtuzumab pharmacokinetic (PK) studies and developed a population PK
model to allow a Precision Dosing strategy to be developed. We applied this Precision Dosing strategy
in a pilot feasibility study of 12 patients with good results. We are requesting funding in this current
application to support a larger phase II study of Precision Alemtuzumab Dosing in pediatric and young
adult patients with non-malignant disorders. We will evaluate the success of our approach in targeting
patients to the ideal therapeutic concentration window of 0.2-0.6mcg/mL on Day 0 and the impact on
the clinical outcomes of immune reconstitution, graft failure, and graft versus host disease.

Public health relevance
Project Narrative This study is relevant to public health because mortality following allogeneic bone marrow transplant remains a major barrier to its use for patients with all diseases which require bone marrow transplant for survival. Reduced intensity and reduced toxicity conditioning regimens that contain alemtuzumab offer the benefit of less toxicity for patients but are still hindered by transplant complications including acute graft versus host disease and graft failure. This study will test a novel Precision Alemtuzumab Dosing strategy to target alemtuzumab levels to an optimal therapeutic range which will decrease graft failure and graft versus host disease and improve immune recovery and patient outcomes.